An Electronic Health Record-Based Tool to Identify Newly Diagnosed Breast Cancer Patients at Risk of Low Social Support

ABSTRACT
Social support, a social determinant of health (SDoH), is a definitive predictor of breast cancer (BC) treatment
and mortality outcomes. Because of the recognition that social support is critical to BC patient outcomes,
clinicians within Kaiser Permanente Northern California (KPNC) have documented information on social
support in the electronic health record (EHR) since the advent of Epic in 2005. However, no EHR-based social
support measure currently exists to help clinicians identify patients at high risk of low social support. Such a
measure has high relevance for addressing racial/ethnic disparities in BC treatment and outcomes. Therefore,
we propose to develop an Electronic Health Record Social Support Patient Risk Tool (EHR-SUPPORT) that
could be used to identify women with BC at risk of low social support for referral to social support resources.
We propose to: 1) Identify terms in the EHR, based on theory and prior literature, and informed by KPNC
stakeholders in BC care, that reflect structural and/or functional social support, and have been associated with
BC treatment and outcomes; 2) Develop EHR-SUPPORT, using structured, semi-structured, and unstructured
data (to include natural language processing of text) that identifies patients at risk of low social support, overall
and by race/ethnicity, and validate the measure against published social support measures; and 3) Evaluate
associations of EHR-SUPPORT and its component variables with BC treatment (surgery and chemotherapy
delays, nonadherence to hormonal therapy) and BC-specific and total mortality, overall and by race/ethnicity in
44,348 women diagnosed with stage I-IV BC within Kaiser Permanente Northern California between 2006-
2023 including 3,450 Black, 4,441 Hispanic, 6,571 Asian women, and 28,589 non-Latina white women. In an
exploratory aim, we will develop, with KP clinician stakeholders, steps to the implementation of EHR-
SUPPORT. We will review 100 medical records (25 in each race/ethnic group) within two months of diagnosis,
informed by investigator expertise and clinician stakeholders, to develop terms used to describe patient
support. In addition to developing structured data, we will use natural language processing of text fields to
further develop social support indicators (Aim 1). EHR-SUPPORT will be computed from social support
indicators; we will use linear and logistic regression to validate the developed measure against established
social support measures in Pathways, a well-established cohort of 4,505 women with BC and use factor
analytic and confirmatory factor analytic methods as well as ROC curves to further evaluate the score (Aim 2).
We will use linear, logistic, and Cox proportional hazards regression to evaluate associations in Aim 3. The
unique convergence of EHR and cohort data provides the first opportunity to develop and validate an EHR-
based social support measure in in diverse women with BC, adjusted for an extensive set of covariates. This
work is central to identifying patients at elevated risk of low social support and to enhancing social support-
cancer research needed to improve clinical care and reduce BC disparities.

Public health relevance
NARRATIVE Social support, a social determinant of health (SDoH), is a definitive predictor of breast cancer (BC) treatment and mortality outcomes and is critical to racial/ethnic disparities in breast cancer (BC) treatment and mortality outcomes. This study will develop and validate an Electronic Health Record Social Support Patient Risk Tool (EHR-SUPPORT) in 44,348 women diagnosed with BC from Kaiser Permanente Northern California. Developing this measure is central to identifying patients at risk of low social support and to enhancing social support-cancer research needed to improve clinical care and reduce BC disparities.